Biomolecular Interactions Core

Summary for the Biomolecular Interactions Core (Core C) led by Core Director Kevin Raney, PhD
Biological systems rely on dynamic interactions between macromolecules to maintain cellular homeostasis
and respond to metabolic cues. Determining the biophysical and biochemical properties of proteins, nucleic
acids, and other macromoleculesincluding the size and composition of multi-subunit complexes and dynamic
interactionsis central to understanding molecular mechanisms and biological function. Each Research Project
Leader (RPL) in the Center for Molecular Interactions in Cancer (CMIC) will use biophysical tools to quantify
the size, stoichiometry, and dynamic nature of macromolecules. The CMIC will leverage available resources,
expertise, and significant institutional support to create a new Biomolecular Interactions Core (Core C) that
will support an important research mission of the center – namely, to use precise and quantitative methods to
define how biomolecules function in cancer. Directed by Kevin Raney, PhD, a nationally-recognized leader in
the field of enzymology, the Biomolecular Interactions Core will be a unique, new core with experienced staff
and state-of-the-art equipment that does not duplicate existing facilities or shared resources at the University of
Arkansas for Medical Sciences (UAMS). The major goal of the core during Phase 1 will be to provide highly-
specialized equipment and educational opportunities to current and future COBRE RPLs, and other Center
members, to determine molecular mechanisms implicated in cancer. To achieve this goal, three Specific Aims
will be pursued: (Aim 1) a new Biomolecular Interactions Core will be established to serve the needs of RPLs
and Center members by facilitating experiments that use quantitative biochemical and biophysical methods to
determine the size, composition, and dynamic interactions of biomolecules and macromolecular complexes
involved in the etiology of cancer, (Aim 2) state-of-the-art services for biophysical and quantitative approaches
to study macromolecules will be developed, and (Aim 3) we will provide training and education related to
quantitative analysis of biomolecules, extending our efforts outwards from the CMIC to the broader research
community at UAMS and other campuses in Arkansas. An important long-term goal is to build a self-sustained
core by establishing a recharge policy and serving as a resource in future program project grants submitted by
CMIC investigators. The Biomolecular Interactions Core fits squarely within the theme of the Center because it
will facilitate rigorous and technically challenging investigations of macromolecules and complexes that have
important roles on processes driving the malignant features of tumors and therapy resistance.